Dissecting the Role of TRPV1 in Triple-Negative Breast Cancer Innervation

PROJECT SUMMARY:
Breast cancer is the most common form of malignancy in women, accounting for almost one in three new female
cancer diagnoses each year. The primary cause of breast cancer-related deaths is metastatic disease, where
tumor cells disseminate to secondary sites in the body. Human breast tumors exhibit increased sensory nerve
fiber density compared to healthy tissue, and increased innervation is associated with higher rates of distant
organ metastasis. Notably, triple-negative breast cancer (TNBC), a highly metastatic molecular subtype, exhibits
increased peripheral nerve innervation compared to other subtypes. Previous work in the Oudin lab
demonstrated that sensory nerves promote the in vitro migration and in vivo metastasis of TNBC cells. The goal
of this project is to uncover the mechanism driving increased sensory nerve innervation in TNBC, which could
provide a novel target to reduce metastasis and improve patient survival. TRPV1 is a non-selective cation
channel present on sensory nerves that drives neurite outgrowth and regeneration. Stimulation of TRPV1
activates the c-Jun transcription factor, which upregulates downstream genes involved in neurite outgrowth, such
as interleukin 6 (IL6). Our preliminary transcriptomic analysis revealed that Il6 and other c-Jun target genes
involved in neurite outgrowth are upregulated when primary sensory neurons were co-cultured with TNBC cells.
I also found that TNBC cells promoted sensory neurite outgrowth and increased c-Jun expression in a TRPV1-
dependent manner. I hypothesize that TNBC cell secretions stimulate TRPV1 on sensory nerves in adjacent
healthy tissue, leading to c-Jun activation and an upregulation in genes associated with neurite outgrowth and
regeneration, such as IL6, ultimately driving neurite outgrowth into the tumor microenvironment (TME). In three
specific aims, I will test this hypothesis and further elucidate how TNBC cells recruit sensory nerves into the TME.
In SA1, I will investigate the role of c-Jun and its downstream targets, such as Il6, in driving TNBC cell-mediated
sensory neurite outgrowth in 2D. In SA2, I will utilize a 3D hydrogel model to determine the effects of TNBC cells
on sensory neurite outgrowth and explore the role of TRPV1 in mediating outgrowth. To our knowledge, this
innovative approach will be the first description of nerve-cancer interactions in a 3D system. In SA3, I will
examine the role of TRPV1 in recruiting sensory nerves into mammary tumors in vivo. This will be completed by
both genetic and pharmacologic inhibition of TRPV1 in a syngeneic mouse model of TNBC. Successful
completion of these aims will provide valuable insights into the mechanism through which TNBC cells promote
sensory innervation into the TME. As innervation drives TNBC cell metastasis, targeting this newly discovered
mechanism could offer a promising clinical strategy to improve patient outcome. Aligned with this research
proposal, a tailored training plan has been designed that integrates clinical and research training to prepare me
for a career as an independent physician scientist.

Public health relevance
PROJECT NARRATIVE: Breast cancer is the most common malignancy in women, and the primary cause of breast cancer-related deaths is when tumor cells spread to other organs, a process known as metastasis. Sensory nerves, which are more abundant in breast tumors compared to healthy breast tissue, can increase breast cancer metastasis. The goal of this project is to reveal the mechanisms by which breast cancer cells attract sensory nerves into the tumor, potentially enabling new therapeutic targets to reduce metastasis and improve patient survival.